Modeling Solute Transport and Urine Concentrating Mechanism in the Rat Kidney

DESCRIPTION (provided by applicant): Modeling Solute Transport and Urine Concentrating Mechanism in the Rat Kidney The goal of this proposal is to use mathematical modeling to investigate aspects of the renal trans- port and dynamics, with an ultimate goal of gaining a better understanding of the mammalian urine concentrating mechanism and solute cycling. Mathematical models of renal tubules and microvessels, coupled with explicit analysis and numerical methods for solving dierential equations, will be used in the following studies: (I) A model of the urine concentrating mechanism of the renal medulla in the rat kidney that represents the relative positions of the tubules and vessels will be developed and used to test the hypothesis: the urine concentrating mechanism of the renal inner medulla of the rat kidney arises from solute mixing in the interstitium, and that mechanism may be comprised of four countercurrent systems, based on the specic 3-dimensional relationships among tubules and vessels. (II) A specic aspect of the 3-dimensional organization in the inner medulla will be considered: interstitial nodal spaces that are bordered by collecting ducts, ascending vasa recta, and ascending thin limbs. A compartment model will be used to test the hypothesis that these microdomains may be essential mixing nodes for targeted delivery and interaction of specic solutes. (III) A dynamic model of the urine concentrating mechanism will be developed and used to track solute (urea, in particular) cycling, to study residence times of solutes, and to study the transient eects of urea loads. The ultimate goal is to gain a better understanding of urea recycling in the renal medulla, and the role of medullary 3-dimensional structure and countercurrent tubular conguration in urea management under physiologic and pathophysiologic conditions. (IV) A slice model of the inner stripe of the rat outer medulla, together with a detailed representation of the epithelial transport processes of the thick ascending limb cell, will be used to study the energy eciency and sodium transport of the thick ascending limbs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Modeling Solute Transport and Urine Concentrating Mechanism of the Rat Kidney Significance. This proposal aims to provide a more complete and quantitative understanding of the means by which the kidney can produce urine that is more concentrated than blood plasma (i.e., that contains more solute per unit volume than does blood plasma). This basic research is relevant to public health, because abnormalities of the kidney's urine concentrating capability are known to cause, contribute to, be a consequence of, or occur along with, a number of important disorders and diseases, including abnormal body water and salt retention or loss. Modeling Solute Transport and Urine Concentrating Mechanism of the Rat Kidney Signicance. This proposal aims to provide a more complete and quantitative understanding of the means by which the kidney can produce urine that is more concentrated than blood plasma (i.e., that contains more solute per unit volume than does blood plasma). This basic research is relevant to public health, because abnormalities of the kidney's urine concentrating capability are known to cause, contribute to, be a consequence of, or occur along with, a number of important disorders and diseases, including abnormal body water and salt retention or loss. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS We will use a series of mathematical models to investigate aspects of the renal transport and dynamics, with an ultimate goal of gaining a better understanding of the mammalian urine concentrating mechanism and solute cycling. More specifically, we will investigate: ¿ the role of medullary 3-dimensional structure in the production of a highly concentrated urine by the rat kidney; ¿ urea cycling, and the role of medullary 3-dimensional structure and countercurrent tubular configuration in urea management, under physiologic and pathophysiologic conditions; ¿ sodium transport of the medullary thick ascending limbs (mTALs) and its energy efficiency, especially under hypoxic condition. SA-I. Urine concentrating mechanism of the rat kidney: Investigate role of microdomains and distin- guishable countercurrent systems. Recent anatomic findings by Dr. Thomas Pannabecker and co-workers have revealed, in the inner medulla (IM) of the rat kidney, complex tubular-vascular patterns and relations, including interstitial nodal spaces that are bordered by collecting ducts (CDs), ascending vasa recta (AVR), and thin ascending limbs (tAL). To better un- derstand the role of these microdomains in the IM concentrating mechanism, we will first develop a compartment model, and use that model to test our hypothesis that these microdomains may be essential mixing nodes for targeted delivery and interaction of specific solutes [74, 113]. The compartment model will then be incorporated into a steady-state urine concentrating mechanism model of the rat renal medulla. That model will represent the 3D structure of the renal medulla, and it will be based on an OM model previously developed by us [72] and on a new second-generation region-based IM model. We will use that model to investigate another hypoth- esis [113, 74]: that the IM concentrating mechanism may be comprised of four distinguishable countercurrent systems, based on the IM 3D structure. SA-II. Urea cycling under physiologic and pathophysiologic conditions. The IM CD clusters and countercurrent tubular configuration likely promote the sequestration and cycling of urea within the renal medulla. We will use the concentrating mechanism model developed in SA-I to test that hypothesis, and to examine the circumstances under which urea management is perturbed in rats under patho- physiologic conditions, e.g., low-protein diet, hypercalcemia, chronic lithium intoxication, etc. We will also seek to better understand the essential roles, in the context of the IM concentrating mechanism, of the cycling of urea by countercurrent exchange within the renal medulla. To accomplish that, we will simulate the urine concen- trating mechanism of a UTB-knockout rat, which is known to have deficient concentrating mechanism function, and study its urea management. We hypothesize that the OM concentrating mechanism is insensitive to the dissipative effects of the vasculature, and that, in contrast, the osmolality gradient generated by the IM con- centrating mechanism is preserved by countercurrent exchange between the descending vasa recta (DVR) and AVR. Finally, we will develop a dynamic model of the urine concentrating mechanism of the rat kidney, and use that model to predict residence times of solutes and to study the transient effects of urea loads. SA-III. Understanding the energy efficiency of mTAL sodium transport. TAL cells are capable of high efficiency Na+ reabsorption by generating a lumen-positive transepithelial electrical potential. That potential drives Na+ passively through the cation-selective tight junctions. Such paracellular Na+ transport may greatly increase the number of moles of Na+ ions absorbed for a given ATP utilization. However, in the OM transmural Na+ concentration gradient favors Na+ entry into the TAL lumen, which limits paracellular Na+ reabsorption and lowers the energy efficiency of Na+ reabsorption. Also, transcellular Na+ transport across TAL cells may be metabolically limited, inasmuch as those cells normally operate near the brink of hypoxia. This is because in the OM, the TALs are located in a region that is far away from the vascular bundles and that has low oxygen tension. To better understand the energy efficiency of the TAL cells, we seek to develop a mathematical model of a cross-section (or, slice) of the inter-bundle region of the inner stripe; that model will include detailed representation of the epithelium of the TAL, and simpler representation of neighboring tubules and vessels. We will use the model to test the hypotheses that basolateral Na+ transport is a limiting factor for mTAL Na+ reabsorption, and that, owing to the sufficiently large interstitial-to-luminal concentration gradient, passive paracellular Na+ transport is negligible compared to transcellular transport.